Synthetic matrices for studies on trophoblast differentiation in 3D culture

PROJECT SUMMARY/ABSTRACT
The trophectoderm layer of the blastocyst stage embryo forms the epithelial cytotrophoblast (CTB), which gives
rise to all trophoblast cell types in the placenta. A vital process during early human placental development is the
differentiation of CTB to extravillous trophoblasts (EVTs), and subsequent invasion of uterine tissue by a subset
of EVTs that have a mesenchymal phenotype. Abnormalities in trophoblast differentiation and invasion are im-
plicated in placenta-related pathologies such as preeclampsia and abnormally invasive placenta. Yet, molecular
mechanisms underlying CTB differentiation in the early gestation human placenta remain poorly understood due
to restrictions on research with human embryos and fetal tissue, and significant differences between early pla-
cental development in humans and animal models. The derivation of human trophoblast stem cells (hTSCs)
from first trimester placentas and blastocyst stage embryos has provided a powerful tool for studying CTB differ-
entiation to EVTs in vitro. However, current 2D culture systems do not provide insight into molecular mechanisms
that regulate EVT differentiation of CTBs in vivo, even though they give rise to EVT cell types in vitro. Current
systems do not incorporate critical cues for differentiation provided by the ECM, or they include non-physiological
differentiation triggers that are not relevant in vivo. Since EVT differentiation involves both matrix degradation
and cell migration, a 3D cell culture system incorporating ECM proteins found in vivo is necessary. We propose
to construct synthetic matrices for use in a 3D cell culture model to investigate EVT differentiation of CTB. In
conjunction with chemically defined media, these matrices will enable mechanistic studies on EVT differentiation
of CTB in 3D culture. We will use human trophoblast stem cells (hTSCs) derived from primary placental samples
to model the CTB. Two specific aims are proposed. In Aim 1, we will construct polymeric hydrogels based on
gelatin methacryloyl (GelMA) with stiffness comparable to published values for the decidua basalis. We will in-
vestigate the effect of incorporating laminin, fibronectin, collagen I, collagen IV, and combinations thereof in
these matrices, on EVT differentiation and invasion in 3D culture. In Aim 2, we will develop a 3D co-culture
system using synthetic matrices to investigate the effect of decidualized and non-decidualized endometrial stro-
mal cells on EVT differentiation and invasion. In summary, our work addresses the critical need for defined in
vitro experimental systems that provide a reasonable representation of in vivo physiology, and lays the founda-
tion for future studies on molecular mechanisms underlying trophoblast differentiation and invasion.

Public health relevance
PROJECT NARRATIVE A critical process during early human placental development is the invasion of uterine tissue by trophoblast cells of the placenta. This project will use a multi-disciplinary bioengineering approach to develop well-defined syn- thetic matrices to serve as physiologically relevant models of trophoblast invasion, thereby enabling studies on early human placental development. Improved understanding of the molecular mechanisms regulating placental development drive can drive novel therapies and preventative strategies to improve the health of human preg- nancies.